Mentoring the next generation of substance use, HIV, and epigenetic researchers in sexual and gender minority health

ABSTRACT
Dr. Annesa Flentje is Associate Professor in Community Health Systems and Department of Psychiatry and
Behavioral Sciences at the University of California, San Francisco. She mentors early career researchers in
sexual and gender minority (SGM, non-heterosexual and transgender or gender non-binary people, respectively)
health, focusing on substance use, minority stress, and epigenomic markers of substance use. SGM people
have greater substance use when compared to their cisgender, heterosexual counterparts. The greater rates of
substance use are attributed to minority stress exposure (unique stress burden due to discrimination and stigma
among SGM people), and substance use increases in the presence of minority stress. Further, unique molecular
profiles of both substance use and minority stress have been observed in sexual minority men living with HIV,
suggesting that alterations in the epigenome may serve as biological markers for substance use. Unfortunately,
research to date is limited because these models have not explicitly compared people living with HIV (PLWH)
and people living without HIV (PLWoH). Further, SGM people have unique hormonal exposures that have been
unaccounted for in research investigating substance use and potential epigenetic biomarkers for substance use
and these hormonal exposures may also be related to alterations in the epigenome. This project will expand Dr.
Flentje’s research program to integrate hormonal exposures and HIV status, to be able to identify epigenomic
markers of substance use in the presence of endogenous and exogenous hormone exposures comparing PLWH
to PLWoH. To support expansion of her research, Dr. Flentje will receive additional training in HIV, hormone
exposures, dominance analysis, and epigenetic bioinformatics analysis. This K24 will support Dr. Flentje in
mentoring patient-oriented researchers in SGM health who will leverage survey and epigenetic data from existing
cohort studies: The PRIDE Study, the MACS/WIHS Combined Cohort Study, and the All of Us Research Program
to 1) understand key minority stress predictors of substance use among SGM people and compare the relative
strength of these predictors between PLWH and PLWoH; 2) identify endogenous and exogenous hormonal
predictors of substance use among SGM people and determine differences in the relative strength of these
predictors among PLWH and PLWoH; and 3) derive minority stress, substance use, and hormonal phenotypes
among SGM people, identify epigenetic markers of these phenotypes, and identify differences in these
epigenetic markers between PLWH and PLWoH. This K24 will support mentorship of early career researchers
in SGM health focusing on substance use, HIV, hormonal biology, epigenomics, and minority stress. It will also
expand Dr. Flentje’s mentorship skills to integrate structures to support mentees in navigating financial
challenges, loan repayment applications, family building, and emotional hardships. As substance use research
among SGM people is an emerging area of study, a national approach to mentorship to promote innovation in
patient-centered research is critical.

Public health relevance
PROJECT NARRATIVE Sexual and gender minority people (including but not limited to people who are LGBTQ+) are at greater risk for substance use, which is related to unique stressors such as stigma and discrimination, and both substance use and this unique stress have biological signatures, suggesting that biological markers of substance use may be developed that could improve substance use treatment. Dr. Flentje proposes to expand her research by integrating hormonal exposures and HIV status into this work, identifying mentees from a range of disciplines including hormonal biology, epigenetics, and HIV, and seeking training to support mentees through financial challenges, loan repayment applications, family building, and emotional hardships. Dr. Flentje will support patient-oriented mentees to identify hormone exposures and stressors relevant to substance use, and identify epigenetic markers of substance use, hormone exposure, and minority stress among people living with or without HIV.